U-Rise at Rowan University

As the 4th-fastest-growing research institution in the U.S., with two medical schools and heavy recent
investment in biomedical research infrastructure and personnel, Rowan University is an emerging leader in
biomedical innovation in the Mid-Atlantic region. Despite this growth, Rowan maintains a strong commitment to
student-centered, experiential undergraduate education. This unique combination makes Rowan University an
optimal environment for a new diversity-enhancing NIH U-RISE training program. U-RISE@Rowan will provide
comprehensive education and training to broadly educate and engage underrepresented (UR) students in
biomedical research opportunities (Aim 1), to build a community of research-driven UR students with the skills
for success in biomedical careers (Aim 2), and to generate a pipeline of highly-qualified UR graduates that
succeed in doctoral-level biomedical careers (Aim 3). The training program will include four stages: RISE &
See; RISE & Strive; RISE & Shine; and RISE & Soar. RISE & See will broadly educate and engage first-year
UR students in biomedical research. Highly-motivated candidates will apply for one of five U-RISE@Rowan
Fellowships. RISE & Strive will build sophomores’ scientific literacy and practical skills through research
experience, foundational coursework, and extracurricular training. RISE & Shine will provide junior trainees
with research-focused coursework, intensive research training, and workshops to build their professional skills.
RISE & Soar will combine external summer research at a partner R1 institution, a capstone thesis, guided
application to Ph.D. programs, and training in scientific citizenship that includes downward outreach by senior
trainees to enhance recruitment of UR students interested in STEM careers. All stages of the program include
co-curricular training that will be accessible to all UR STEM students interested in biomedical research, with
the goal of broadly enhancing UR engagement in undergraduate research and pursuit of biomedical research
careers. U-RISE@Rowan will leverage the diversity and unique undergraduate-driven, research-focused
environment of Rowan to create a sustainable, scalable program that will yield long-term, far-reaching impact
on the diversity of the biomedical doctorate research community.

Public health relevance
Project Narrative The U-RISE at Rowan University training grant supports research-focused training of underrepresented undergraduate students from the College of Science & Mathematics. This comprehensive training program combines coursework, extensive hands-on biomedically-relevant research experiences, interactive workshops, and networking events to prepare trainees for success in biomedically-related doctoral programs.